Immunometabolic Regulation of Adipose Tissue by CTRP6

PROJECT SUMMARY
Macrophages respond to stimuli in their microenvironments, altering their polarization to M1 pro-
inflammatory or M2 anti-inflammatory phenotype. Targeting macrophage polarization provides a
promising therapeutic strategy for obesity-related inflammation and insulin resistance. C1q/TNF-related
protein 6 (CTRP6), a member of a highly conserved secreted protein family, has recently been found
to be involved in the functional regulation of adipose tissue. In Ctrp6 knockout (KO) mice fed with high-
fat diet, the expression level of M1 macrophage marker gene TNF-a was significantly down-regulated
in white adipose tissue as well as in serum, suggesting the reduced inflammation. In RAW264.7
macrophage cell line, CTRP6 recombinant protein reduced the expression of M2 macrophage marker
gene CD206 at lower doses while induced TNF-a expression at higher doses, indicating its important
role in both suppressing M2 polarization and promoting M1 polarization. Interestingly, CTRP6
recombinant protein can be detected in the nuclear after it was added to the cell culture medium,
indicating it is a secreted nuclear protein. Thus, the objective of the proposal is to confirm knocking out
CTRP6 gene in macrophages polarizes them to anti-inflammatory phenotype and further develop a
cell-based therapy to attenuate adipose tissue inflammation and insulin resistance via injecting
CRISPR/Cas9-mediated CTRP6 KO macrophages. The program will be carried out in three specific
aims: 1) determine the anti-inflammatory phenotype of CTRP6 KO macrophages by performing
transcriptome profiling, functional analysis and metabolic analysis; 2) determine the impact of CTRP6
KO macrophages on adipocyte insulin sensitivity in a co-culture system by assessing glucose uptake,
GLUT4 translocation, insulin and other signaling pathways; 3) develop cell-based therapy using
CRISPR/Cas9-mediated CTRP6 KO macrophages to ameliorate insulin resistance by evaluating
adipose tissue inflammation and systemic insulin sensitivity. The proposed research is significant,
because it will not only contribute to a fundamental understanding of macrophage polarization in the
setting of adipose tissue inflammation and insulin resistance, but also lay the groundwork for the
development of potential cell therapy for obesity using genetically modified macrophages. In addition,
this proposal will enhance the infrastructure of research and education at Oklahoma State University,
introducing biomedical research to undergraduate students especially underrepresented minority and
female students. This would allow them to experience a broad spectrum of techniques, and acquire
skills such as molecular cloning, cell culture and mouse models, which are widely used in modern
scientific investigations.

Public health relevance
PROJECT NARRATIVE As obesity has become pandemic globally, and it is highly associated with diabetes, hypertension, cardiovascular diseases and several types of cancer, there is an urgent need to develop efficient therapeutic approaches to treat obesity. Since targeting macrophage polarization is a promising strategy, we here propose to verify the deletion of CTRP6 gene could polarize macrophages to anti- inflammatory phenotype as well as develop a cell-based therapeutic strategy using genetically modified CTRP6 knockout macrophages. These studies will significantly contribute to the fundamental knowledge of molecular regulation of macrophage polarization involved in the pathogenesis of adipose tissue inflammation and insulin resistance and bring light upon effective immunotherapy for obesity.